Clinical Core

The Clinical Core (CC) of the Center of Excellence for Research on Complementary and Integrative
Health (CERCIH) will facilitate the clinical activities of the three proposed Projects, providing support
and expertise to unify all clinical aspects of our human subjects experimental designs. The CC will
recruit, screen, characterize, and enroll 120 subjects with recurrent migraine headaches and 30 age-­
and gender-­matched healthy controls. Mostly using physician referrals and our Research Patient Data
Registry (RPDR), the core will utilize a highly skilled and experienced team to supervise and implement
these goals. The CC will be the central randomization point for Projects 1, 2, and 3 and provide the
network and referrals to support recruitment of all subjects and ensure adherence to the common
inclusion/exclusion criteria utilized for all three Projects. The CC will randomize subjects using a 2 x 2
design: Mindfulness-­Based Stress Reduction (MBSR) versus Health Education Training (HET) X
transcutaneous vagus nerve stimulation (tVNS) compared to sham tVNS. The CC will ensure that the
MBSR and HET are delivered correctly and adhere to protocol. The CC will recruit, train and supervise
the MBSR group leaders who will perform all of the necessary trainings and education sessions. The
CC will refine and implement the methodologies, including audiotaping and fidelity rating of training
sessions, to ensure group leader protocol compliance. The CC will use accelerometer-­based, ecologic
momentary assessment to measure mindfulness practice dose during the study so as to ensure
accurate measurement of individual subjects’ level of mindfulness practice. The CC will oversee and
integrate our respiratory-­gated tVNS approach with MBSR and HET sessions, including the sham
tVNS, where needed. The CC will ensure that devices will be available to accommodate all subjects
and that the units are reliably utilized within each session. In collaboration with the biostatistics core,
the CC will collect self-­report measures to investigate relevant clinical correlates such as headache
frequency and intensity, days of lost function, perceived stress, and pain interference. The CC will also
collect self-­report data for mediation and moderation analyses, including chronic disease self-­efficacy,
perceived control, anxiety, depression, trait mindfulness, mindfulness practice behaviors, self-­
compassion, interoceptive awareness, and emotional dysregulation. While infrequent, the CC will be
available to provide medical coverage and assessment for any medical or psychiatric adverse effect
from tVNS and/or mindfulness. The CC will meet once per year with the Data Safety Monitoring Board
to review and discuss any new internal or pertinent external data, as well as to monitor safety,
effectiveness, and study conduct. The CC will also coordinate any necessary independent monitoring
activities as required, and successfully manage one common IRB across the 3 projects.